Family Input for Quality and Safety Dissemination and Implementation

Abstract
Adverse patient safety event rates remain stubbornly high in hospitals. For children, adverse events are 1.5-2
times more common than in adult inpatients (40.0 vs. 25.1 harms/100 admissions). Family members and
patients are often close observers of care, focusing on only one patient and one set of diagnoses. Text
messaging and mobile phone applications technologies offer the opportunity to gather patients’ and families’
safety reports in real-time, addressing limitations of prior work. The PI and team co-designed a mobile phone-
based approach, the Family Input for Quality and Safety (FIQS) with families and clinicians. They tested it
across 3 local hospitals and 9 units, successfully engaging family members, patients, staff, and safety and
quality leadership, and leading to safety improvement projects. The objectives of this proposal are to address
key outstanding dissemination and implementation questions, focusing on minimizing sign-up burden,
supporting ongoing participant engagement, and enhancing related safety efforts, informed by the CFIR
framework. Aim 1: In a cluster-randomized study (n=5645, 15 units), assess the effect of two sign-up
strategies (text only, text with in-person orientation) on reporting rates, and interactions by race, ethnicity, &
language. Hypothesis: Rates of enrollment and safety-oriented reporting will differ between strategies. Aim 2:
In a 1:1 randomized trial, test the effect of two engagement strategies on patient and family safety reporting
rates, and interactions by race, ethnicity, & language (n=3386). Group 1 participants: Reports will be shared
with units without identifiers (unless requested). Group 2 participants: All reports are shared with units with
identifiers. Hypothesis: Reporting rates will be higher for those whose reports are not identified, who access
the website, and for whom there is service recovery; results may vary by race, ethnicity, or language. Aim 3:
Using mixed methods, evaluate barriers and facilitators to the successful integration of FIQS data into safety
efforts. Over an 18-month implementation period, in 21 units, assess inner drivers of uptake & outcomes.
Quantitative outcomes: # of units integrating FIQS report reviews into existing safety workflows; numbers of
FIQS reports reviewed, # of system-level interventions undertaken and completed. Qualitative data:
characterization of interventions made in response to FIQS reports; barriers and facilitators of successful
integration of FIQS reports into safety. The proposed research is innovative in its paradigm-shifting conceptual
model of 1) its use of mobile phone technology for real time safety reporting, with highly feasible patient-level
randomization, and 2) text-message based opt-out approach, to engage patients and caregivers to share
safety observations, moving prior evidence into real-world implementation. The contribution of the research will
be to answer key dissemination and implementation questions about using patient-facing digital technology to
improve patient safety, in partnership with unit leaders and families. These contributions will be significant
because they are key to implement and evaluate a potential new approach to improving inpatient safety.

Public health relevance
Project Narrative The proposed research is meaningful to public health because it aims to address ongoing gaps in inpatient pediatric safety. This project is directly relevant to NICHD’s focus on dissemination and implementation of scientific advances that will improve pediatric patient health, focusing on pediatric inpatient safety.